Administrative Core

Abstract
Project program grants are intended to bring together several research projects centered about a common, well-defined purpose. Our proposal aims to address fundamental challenges in the treatment of AML. The strategy for scientific integration will be implemented by our Administrative Core as an administrative and communication hub to facilitate scientific integration.

The Administrative Core will provide management of each of the Projects and Cores in this Program, will monitor scientific progress, and will coordinate efforts. As described in previous funding cycles, the Administrative Core will continue to provide financial, administrative, and clerical services for the PI, Project Leaders, and Core Leaders for all grant-related activities. This will include preparing any competing renewal, non-competing renewals, progress reports, budgets, communication with the NIH regarding renewals and all financial interactions, and assurance that the labs supported by this Program are in full compliance with all institutional, state and federal regulations. The Administrative Core will also coordinate and schedule all meetings related to the function of the Program, including bi-monthly meetings of all Project and Core leaders, key members of their respective laboratories, and annual meetings of the Internal and External Advisory Boards.

Dr. Benjamin Ebert and Dr. Scott Armstrong, the co-PIs and co-Directors of this Core, will serve as the overall scientific directors and chief administrators, and Dr. James Griffin will serve as a senior advisor to this Program, focusing on scientific oversight, and the allocation of funds and other resources. If Dr. Ebert is unable to continue his duties as PI, Dr. Scott Armstrong would assume these responsibilities. Ms. Chanel Logan will serve as Administrative Facilitator, managing budgets, preparing reports including non-competing renewals, interfacing with the financial officers, and serving as an interface between these groups and the NIH. Dr. Dora Levin will work with Ms. Logan to assure compliance and appropriate regulations regarding experimentation with human subjects, and vertebrate animals, as well as compliance of publications, IRBs and IACUCs for all the projects. Ms. Logan and Dr. Levin will work closely with Dr. Ebert and Dr. Armstrong on the preparation of all necessary documents related to the activities in this Program Project grant.

Public health relevance
Narrative Our proposal aims to address fundamental challenges in the treatment of AML by building on recent advances in understanding the biology and treatment of myeloid malignancies, leveraging protein degradation as a novel tool to overcome gaps in the druggable proteome, and discovering and developing novel agents to target a variety of dependencies in leukemia. Our Administrative Core will provide management to each of the Projects and Cores, monitor scientific progress, coordinate efforts, and provide financial, administrative, and clerical services for all grant-related activities.